Administrative Diversity Supplement for Aimee Potter

PROJECT SUMMARY/ABSTRACT
Neisseria gonorrhoeae (Ngo) is the bacterium that causes the sexually transmitted infection gonorrhea.
Infection with Ngo triggers a potent inflammatory response at mucosal epithelial surfaces that is characterized
by recruitment of neutrophils, which are unable to clear the bacteria. With mounting antibiotic resistance in
Ngo, new therapeutics are urgently needed to treat gonorrhea, and one promising approach is to combat its
dependence on metals such as iron and zinc that are acquired from its obligate human host. In humans and
other mammalian hosts, essential metals are found within high affinity complexes with proteins and are not
freely available. Examples of these proteins are the iron-binding transferrin and hemoglobin, found in
abundance in serum/erythrocytes, and zinc-binding lactoferrin and calprotectin, which are found in abundance
in neutrophils as well as mucosal secretions. To overcome this restriction (“nutritional immunity”), Ngo
produces outer-membrane, surface-exposed transporters that bind to human metal-binding proteins and
extract the metal from them directly, via energy supplied by the TonB system. There are 8 known TonB-
dependent transporters (Tdts) in Ngo. Four Tdts are the focus of the parent application: TdfH and TdfJ, which
bind to human calprotectin and psoriasin, respectively, to acquire zinc; and TdfF and TdfG, which are iron-
regulated but whose ligands and functions remain undefined. Four other Tdts are involved in metal acquisition
in Ngo: TbpA, which binds human transferrin; LbpA, which binds human lactoferrin; HpuB, which binds human
hemoglobin; and FetA, which binds ferric enterobactin, a siderophore produced by members of the microbiota.
In this diversity supplement application, we propose three Specific Aims that are independent of the parent
R01 award: 1) Test the role for TbpAB, FetAB, and HpuAB in survival and outgrowth of Ngo exposed to
primary human neutrophils, including the necessity for ligand binding and TonB-dependent transport; 2)
Determine the bioavailable metals and their cognate metal-binding proteins that are available to Ngo during
infection of neutrophils; and 3) Define the metabolic pathways Ngo differentially uses in metal-depleted and
metal-replete growth conditions. The latter Aim will leverage a recent genome-scale metabolic network
reconstruction our lab recently created, contextualized with publicly available metal-dependent transcriptional
datasets of Ngo. Completion of these Aims will reveal new insights into the response of Ngo to human
nutritional immunity and uncover new biology for future mechanistic investigation at this host-pathogen
interface. It will provide the diversity supplement postdoctoral trainee with defined training in bacterial genetic
manipulation and neutrophil functional assays, while engaging the trainee in the interdisciplinary research
taking place under the auspices of the parent R01. At the same time, the trainee will develop career transitional
skills and uncover new research foci, which will help her achieve her career goal of becoming an independent
tenure-track principal investigator in Ngo biology and pathogenesis.

Public health relevance
PROJECT NARRATIVE Neisseria gonorrhoeae (Ngo) remains a worldwide “superbug” public health threat. We seek to define the ways that Ngo acquires essential metals like iron and zinc from its obligate human host, which may be potential targets for new treatments against drug-resistant gonorrhea. The research in this diversity supplement will investigate how Ngo accesses these metals when confronted with neutrophils of the human immune system and how Ngo metabolism is affected under varied metal conditions.